KICKOFF MEETING

The purpose of this meeting was for the new awardee and the Government to discuss and address any questions the Contractor might have regarding the new NCI Biomedical Computing contract.